Mechanisms of Visual Motion Perception

DESCRIPTION (provided by applicant): Visual processing faces two conflicting demands: integration and segmentation. Integration is required by inherently noisy visual signals, while segmentation is needed to extract vital information from spatiotemporal variations in visual input. An understanding of the interplay between these two mechanisms will reveal fundamentals of visual processing and also enable insights into functional roles of segmentation processes. In motion perception, the PI's recent work demonstrated that spatial integration of motion signals is not fixed, but critically depends on basic visual factors such as contrast, with spatial integration giving way to spatial suppression as stimulus visibility increases. The overarching goal of this proposal is to investigate the neural mechanisms involved in this adaptive integration/segregation of motion signals, and to elucidate their role in the segmentation of objects from moving backgrounds. The key property of spatial suppression is impaired motion perception of large, high-contrast stimuli. In Aim 1, we will determine if and how this suppressive mechanism affects visual and oculomotor processing. Answering this question will constrain possible neural correlates of spatial suppression and, along with Aim 2, provide a test for the hypothesis linking spatial suppression to surround suppression in area MT. Substantiating this link will allow the attribution of links between spatial suppression and motion segregation (Aims 2 & 3) to the involvement of MT surround suppression. In Aim 2, we will seek direct evidence about neural correlates of spatial suppression by impairing processing in MT and early visual areas with TMS. We expect that a disruption of neural mechanisms critically involved in spatial suppression will allow normally suppressed motion signals to reach perception. Concurrently, we will also determine whether the same stimulation that impairs spatial suppression also disrupts motion segregation. In Aim 3, we test the hypothesis that spatial suppression directly enables rapid segregation of moving objects by suppressing background motion signals. Here, the role of spatial suppression in motion segregation is conceptualized as a coarse, but rapid, region-based segmentation process. This hypothesis predicts that variations in spatial suppression (and, thus, in the visibility of background motion) should predict corresponding changes in motion segregation and vice versa. Exploiting different experimental approaches, we will test this prediction by utilizing stimulus manipulations, individual differences and perceptual learning to produce variations in either spatial suppression or motion segregation. One focus will be on older adults, who are known to exhibit weak spatial suppression. We will determine whether this abnormality predicts motion segregation deficits and whether age-related deficits in spatial suppression can be reversed by the perceptual learning of motion segregation.

Public health relevance
PUBLIC HEALTH RELEVANCE: The knowledge of mechanisms underlying spatial suppression and motion segregation will contribute to the understanding of age-related changes in these two basic visual processes. Moreover, understanding how these age-related deficits can be alleviated through perceptual learning might lead to the development of viable interventions. The knowledge of mechanisms underlying spatial suppression and motion segregation will contribute to the understanding of age-related changes in these two basic visual processes. Moreover, understanding how these age-related deficits can be alleviated through perceptual learning might lead to the development of viable interventions. __SpecificAimsTextDelimiter__ A. Specific Aims Visual processing faces two conflicting demands: integration and segmentation (Braddick, 1993). Integration is required by inherently noisy visual signals, while segmentation is needed to extract vital information from spatial and temporal variations in visual input. The appropriate balance between integration and segregation is important, as excessive integration will average over useful information, while aggressive segmentation could enhance spurious signals. An understanding of the interplay between these two mechanisms will not only reveal fundamentals of visual processing, but also enable better insights into the functional roles of the segmentation processes in vision. In motion perception, the PI's recent work demonstrated that spatial integration of motion signals is not fixed, but critically depends on basic visual factors such as contrast, with spatial integration giving way to spatial suppression as stimulus visibility increases. The overarching goal of this proposal is to investigate the neural mechanisms involved in this adaptive integration/segregation of motion signals, and to elucidate their role in the segmentation of objects from moving backgrounds. Aim 1 What are the effects of spatial suppression on visual and occulomotor processing? Motion discriminations of high-contrast stimuli worsen with increasing size. This finding, described as spatial suppression, is hypothesized to reflect surround suppression mechanisms in area MT. In MT, surround suppression is not inherited from feedforward inputs and reflects properties of antagonistic center-surround, but not wide-field MT neurons. This indicates the existence of motion processes that are not affected by suppressive MT interactions: those that reflect early motion mechanisms (e.g., V1) and those that are in parallel (e.g., wide-field occulomotor mechanisms). Here, we ask whether those same processes are unaffected by psychophysical spatial suppression. Answering this question will further constrain possible neural correlates of spatial suppression and, along with Aim 2, provide a test for the hypothesis linking spatial suppression to surround suppression in area MT. Substantiating this link will allow for the attribution of links between spatial suppression and motion segregation (Aims 2 & 3) to the involvement of MT surround suppression. Specifically, we will investigate whether motion stimuli exhibiting full spatial suppression can nevertheless yield static and dynamic motion aftereffects (MAEs, Aim 1.1) and induce ocular following reflexes (OFRs, Aim 1.2). OFRs are of interest because they are likely driven by wide-field motion mechanisms, and thus potentially immune to spatial suppression. MAE is particularly useful for our purposes because an appropriate selection of the MAE test stimulus allows selective inferences about low- and high-level motion mechanisms. Aim 2 Do spatial suppression and motion segregation share common neural correlates? Guided by Aim 1 pilot results showing that a significant amount of motion processing takes place under conditions of full spatial suppression, we hypothesize that a disruption of neural mechanisms critically involved in spatial suppression could allow normally suppressed motion signals to reach perception. Such experimental manipulation should yield improved motion perception of large, background-like motions, and, according to the functional hypothesis detailed in section B, impairments in motion segregation. Specifically, we will use transcranial magnetic stimulation (TMS) to impair neural processing in MT and early visual areas. Changes in spatial suppression and motion segregation will be measured following both repetitive (Aim 2.1) and single-pulse TMS (Aim 2.2), allowing insights in the temporal dynamics of studied processes. These TMS results will be compared to spatial suppression and motion segregation deficits found in older adults (Aim 3). In sum, these studies will determine whether spatial suppression and motion segregation share neural correlates, setting the stage for a closer investigation of the links between these two processes in Aim 3. Aim 3 Is spatial suppression in motion functionally linked to motion segregation? The basic hypothesis is that mechanisms of spatial suppression directly enable rapid segregation of moving objects by suppressing background motion signals. Here, the role of spatial suppression in motion segregation is conceptualized as a coarse, region-based segmentation that does not require extraction of motion-defined edges. This hypothesis predicts that variations in spatial suppression (and, thus, in the visibility of background motion) should predict corresponding changes in coarse motion segregation and vice versa. Specifically, Aim 3.1 will utilize stimulus manipulations to modulate background motion visibility (i.e., spatial suppression), and determine if these manipulations can predict corresponding improvements/impairments in coarse, but not fine, motion segregation. Also, we will experimentally distinguish between region- and edge- based segregation mechanisms. Aim 3.2 will establish whether individual variability in the strength of spatial suppression predicts differences in observers' ability to segregate moving objects from backgrounds. Additional focus will be on older adults who exhibit weak spatial suppression, as evident by enhanced motion perception of large, high-contrast stimuli. We hypothesize that this unique age-dependent 'improvement' comes at the cost of impaired motion segregation. Aim 3.3 will investigate whether improvements in motion segregation brought on by perceptual learning yield corresponding decreases in sensitivity to large, background- like motions. This hypothesis will be tested in both young and older adults, determining whether age-related deficits in spatial suppression can be reversed by the perceptual learning of motion segregation.